Diabetes Translational Research Core

The Yale-DRC Translational Research Core promotes novel and cutting edge clinical research in diabetes and
related metabolic disorders with the ultimate goal of developing strategies that may lead to the treatment,
prevention or ultimately the cure of diabetes. The role of this core is translational: to enable Yale DRC
investigators to harvest the discoveries in basic medicine, and to apply them to investigations to understand
human pathophysiology. While animals models and studies in vitro provide insights into human pathobiology,
the processes in humans may not be equivalent to these experimental systems, therefore ultimately, to gain
knowledge about human disease, studies with humans are necessary. The Overarching Aim of the Yale DRC
Translational Research Core is to provide the infrastructure required to support Yale’s large group of NIH-
funded clinical investigators, who are conducting clinical diabetes research including those serving as Yale
Principal Investigators in NIDDK multi-center studies. During the current grant period, this objective has been
extended to include a full range of support for an outstanding group of emerging young physician investigators
engaged in diabetes research at the Schools of Medicine, Nursing and Public Health. The primary purposes of
the Yale-DRC Translational Research Core are to: 1) in a cost-effective manner provide specialized clinical
and translational research infrastructure for the investigators to conduct complex diabetes-related studies (e.g.
insulin-glucose clamps, magnetic resonance imaging or spectroscopy studies; PET studies, stable isotope
infusions; indirect calorimetry; body composition; muscle biopsies, dietary interventions and closed-loop insulin
delivery) in adults and children with diabetes and related metabolic disorders, 2) centralize personnel and
practices, provide services and reduce the costs, for the Yale DRC membership to enable and facilitate
translational studies. By providing these services, a broad range of investigators may conduct studies with
human material. In addition, through collaborations with the Yale Center for Clinical Investigation, services
needed to conduct investigator-initiated clinical trials are provided, 3) support the training of clinical scientists
who can fulfill the Yale DRC research mission and emerge as leaders in translational investigations. In summary,
the Yale DRC Translational Research Core, which stands alone in its translational mission, represents a vital
asset of the Yale DRC in fulfilling its objectives.